Using Modern Data Science Methods and Advanced Analytics to Improve the Efficiency, Reliability, and Timeliness of Cardiac Surgical Quality Data

Within existing national surgical quality improvement (QI) programs, there are numerous opportunities to
improve the efficiency of data flow from the point of collection to the time at which performance-based
feedback is provided to stakeholders. Current limitations of the QI data cycle include: (a) reliance on hand
abstraction for data collection; (b) a retrospective and episodic (e.g.: quarterly, bi-annually, etc.) approach to
analysis and feedback which creates a time lag from when the hospital’s performance is declining and when it is
made aware; (c) small clusters of clinically meaningful poor performance may go of undetected using current
episodic analytic structures. To address the first limitation, modern data science methods (MDSMs) could be
used to automate the collection of some, or all, of the variables within surgical QI registries. Full or partial
automation of data collection could allow the substantial resources currently committed to manual data
abstraction to be repurposed to support more continuous, proactive engagement in local QI activities. To
address the limitations associated with episodic performance evaluation, alternative approaches for analyzing
data in more real-time could be applied to provide an early warning of declining performance. The Veterans
Affairs (VA) Surgical Quality Improvement Program (VASQIP) is one of the most successful and longest-
standing national clinical registries used for surgical QI and has been the template for a number of similar
programs in the private sector. As such, VASQIP represents an excellent model for evaluating alternative
approaches to data collection and analysis that could allow for more efficient data flow through the quality
improvement cycle and enhance national surgical QI efforts. The overall goal of this proposal is to evaluate
alternative, potentially more efficient strategies that can be readily implemented within the existing
infrastructure of contemporary surgical QI programs and aid in the more efficient flow of data. The specific
aims are to: (1) develop and validate MDSMs to use structured and unstructured electronic health record data
to automate cardiac VASQIP data collection; (2) compare the risk-adjusted CUSUM (a statistical process
control methodology borrowed from industry) to quarterly observed-to-expected ratios (i.e.: VASQIP’s current
approach to assessing performance) for evaluating VA hospital cardiac surgical performance; (3) conduct semi-
structured interviews with diverse stakeholder groups to set a national research agenda for expansion and
improvement of surgical QI programs. This mixed-methods proposal will involve observational studies using
VASQIP and VA Corporate Data Warehouse data for patients who underwent cardiac surgery at a VA hospital
between 2016 and 2020 as well as qualitative interviews with stakeholders who can help to inform future
changes that can improve the data available within VASQIP. This project is important and novel because it will
provide real-world, generalizable data that can be used to inform national surgical and non-surgical QI
initiatives within VA and the private sector.

Public health relevance
Existing national surgical quality improvement programs have not significantly updated their processes for data collection, data analysis, or providing feedback to stakeholders in decades. Alternative strategies that could be implemented within quality improvement programs’ current infrastructure could make these programs more timely, efficient, and effective. This mixed-methods proposal will evaluate the extent to which such alternative approaches could be used to improve existing national surgical quality improvement programs.